Hippocampal-cortical mechanisms of altered memory consolidation in epilepsy

PROJECT SUMMARY/ABSTRACT
This application presents a five-year mentored research and training plan that will prepare Dr. Sharon Chiang to
be a leader in the field of hippocampal-cortical neuronal microcircuits in memory in epilepsy. Dr. Chiang
completed her MD at Baylor College of Medicine and her PhD in Statistics at Rice University, where she was
trained as a Bayesian statistician in the lab of Dr. Marina Vannucci, and is now a Clinical Fellow in Neurology at
the University of California, San Francisco, in the Division of Epilepsy. Dr. Chiang's long-term career goal is to
advance our understanding of the cellular circuits underlying memory in epilepsy and to investigate targeted
manipulations to improve memory. This project will lay the basis of foundational studies for her independent
research program focused on these aspects.
Temporal lobe epilepsy (TLE) is the most common epilepsy in adults and affects more than 50 million people
worldwide. There are no effective treatments for memory dysfunction in TLE, which stems from a lack of
understanding of the fundamental mechanisms underlying memory impairment. Initially after an experience, the
hippocampus repeatedly “replays” the memory at compressed timescales and transfers the memory to long-term
storage in the neocortex. This replay of memories and the formation of a stable, long-term representation of the
memory in the neocortex are critical to intact memory formation. Whether these critical elements are abnormal
in TLE, and may be potential targets for manipulation, is unknown. This proposal leverages high-density, in vivo
single neuron recordings in the hippocampus and neocortex in an experimental rat model of TLE, combined with
real-time neurofeedback and electrical stimulation, to test the hypothesis that memory replay and formation of
cortical memory-supporting neuronal ensembles are abnormal in TLE and that manipulations targeting these
steps will improve memory. This work will generate fundamental knowledge about the role of two key neural
circuitry steps in memory in TLE and may open avenues to new classes of targeted therapeutic manipulations.
The proposed career development plan includes training in high-density flexible polymer probes, real-time
neurofeedback, and electrical stimulation. Dr. Chiang will learn all of the skills needed for an independent
research career, including mentoring/supervising trainees/staff, grant-writing, and scientific communication. She
has assembled a world-class mentorship team with complementary expertise in hippocampal physiology, sharp-
wave ripples, and memory (Primary mentor, Dr. Loren Frank); inhibitory microcircuits and closed-loop
interventions in epilepsy (Scientific Advisor, Dr. Ivan Soltesz); rodent models of epilepsy and high-frequency
oscillations (Scientific Advisor, Dr. Laura Ewell); electrical stimulation (Dr. Vikram R. Rao); neuroethics and
rodent/human translation (Scientific Advisor, Dr. Daniel H. Lowenstein); and histopathology (Scientific Advisor,
Dr. Cathryn Cadwell). Dr. Chiang, her mentors, and the Department of Neurology at UCSF are fully committed
to this proposal and her development into an independent physician-scientist by the end of this training period.

Public health relevance
PROJECT NARRATIVE Memory is one of the most fundamental human cognitive functions, and the loss of memory is a devastating consequence in epilepsy, which affects more than 65 million people worldwide. In this application, I will combine single-neuron recordings from the hippocampus and cortex with advanced neural signal processing techniques in a rat model of epilepsy to investigate how memories are impaired in epilepsy and to test two potential therapies for ameliorating impairment. This will have important relevance for basic neuroscience, clinical neurophysiology, and targeted therapeutics for memory in epilepsy.